Core--Center for Patient-Centered Interventions (Administrative)

Specific Aim 1: Manage the CPCI through its committee structure The objectives by which we will achieve this aim are: 1. Administer resources according to personnel and budgetary decisions made by the Executive Committee. 2. Communicate between the CPCI and the School of Nursing administration and faculty, and other UW-Wisconsin units, e.g., the Graduate School. 3. Convene the Advisory Council (AC) and implement their suggestions. 4. Recruit additional CPCI investigators. 5. Evaluate the Shared Resources. 6. Evaluate the Administrative Core, coordinate evaluation of the Pilot Studies Core, and conduct an overall evaluation of the CPCI. 7. Prepare yearly Project Reports and the final report. Specific Aim 2: Develop and manage the Shared Resources that will support innovative research on patient-centered interventions The objectives by which we will achieve this aim are: 1. Establish and implement a Research Facilitation system for identifying, recruiting, enrolling, tracking, and collecting data from human subjects. 2. Establish and implement a data management and analysis shared resource.